Supraphysiologic Shear Stresses Associated with Cardiopulmonary Bypass are Sufficient to Activate RIKP3 Signaling

The vast majority of pediatric open-heart surgeries require the patient to be supported by cardiopulmonary
bypass (CPB). Exposure to CPB causes systemic inflammation and resultant multi-organ dysfunction. Post-CPB
inflammation is believed to be caused by exposure of the patient’s blood cells to the plastic tubing of the CPB
circuit and unphysiological high shear stress. However, the mechanisms underlying this process are unclear.
Our long-term goal is to understand how these insults contribute to post-CPB inflammation and translate this
knowledge into novel treatment strategies. The scientific premise for this project is that Receptor-Interacting
serine/threonine-Protein Kinase 3 (RIPK3) signaling is a novel mediator of CPB associated inflammation that
can be targeted to improve outcomes for neonatal cardiac surgery patients. Data from neonatal CBP patients, a
large animal model of CPB, and in vitro experiments form the basis of our scientific premise. We recently
published that RIPK3 and necroptosis play a role in post-CPB inflammation. Our data demonstrate that RIPK3
plays a role in post-CPB inflammation. We established that supraphysiologic shear stresses present during CPB
are sufficient to activate RIPK3 signaling in vitro and in a piglet model of CPB. Mechanistically, we found that
shear stress-initiated calcium signaling pathways are critical to the activation of monocytic cells. We have
identified specific pathways that can be targeted with small molecules to reduce CPB-activation of RIPK3 with
goal of reducing systemic inflammatory response and organ dysfunction. We hypothesize that CPB-associated
shear stress activates RIPK3 mediated inflammation. The objectives of this proposal are 1) to determine how
CPB activates RIPK3 signaling, 2) elucidate how RIPK3 signaling contributes to CPB-associated
inflammation/organ dysfunction, and 3) determine if blocking RIPK3 signaling is sufficient to reduce CPB-
associated inflammation and organ dysfunction. Our approach will consist of two specific aims:
Aim 1. Determine how shear stress activates RIPK3 signaling in circulating myeloid cells.
We postulate that supraphysiologic shear stress is sufficient to activate RIPK3 signaling. We will characterize
the shear stress thresholds and molecular mechanism responsible for RIPK3 activation during CPB with a focus
on the roles that the cell cortex, calcium signaling cascade, and shear responsive kinases play in this response.
Aim 2. Demonstrate that RIPK3 signaling mediates CPB-associated inflammation and organ dysfunction.
We postulate that RIPK3 signaling is required for the inflammatory response to CPB. RIPK3 can help propagate
inflammation via necroptosis, the release of cytokines, and leukocyte migration. We will perform in vitro and in
vivo experiments to demonstrate that targeting RIPK3 signaling reduces CPB-associated inflammation.
This research is novel and significant – elucidating how CPB activates RIPK3 signaling and necroptosis could
enable a new treatment paradigm for CPB patients, improve outcomes, and reduce healthcare costs, since the
proposed signaling pathways can be targeted by small molecules in clinical use or pre-clinical development.

Public health relevance
PROJECT NARRATIVE This project examines how being on cardiopulmonary bypass activates a severe inflammatory response that impairs the function of all most every organ in the body, especially in infants. We will test how a pro-inflammatory molecule is activated by bypass, how this molecule causes damage to organs, and if blocking this molecule reduces post-bypass inflammation/organ damage. The resulting data will be used to help new ways of protecting infants during cardiac surgery.